Molecular analyses of RECQ1 functions in genome maintenance

DESCRIPTION (provided by applicant): The RecQ helicase family is a group of highly conserved DNA unwinding enzymes critical in guarding genome stability in all kingdoms of life. Human RecQ homologs include RECQ1, BLM, WRN, RECQL4, and RECQ5. Although the five human RecQ proteins are similar in their catalytic core and share certain biochemical properties in vitro, they are clearly not redundant. Mutations in BLM, WRN and RecQ4 are associated with distinct genetic disorders of Bloom, Werner, and Rothmund-Thomson syndromes, respectively. Thus, a defect in one RecQ protein is sufficient to cause genomic instability that cannot be compensated by other RecQ homologs. However, what makes each RecQ protein unique is not understood. Dissecting the functions of each human RecQ helicase, and comparing the similarities and differences among them, will reveal which aspects of RecQ functions in DNA metabolism are essential for genome maintenance. The goal of this proposal is to examine molecular functions of RECQ1, the most abundant but least characterized human RecQ helicase homolog. Recently, we have shown that RECQ1 is essential for genome stability maintenance; its deficiency induces accumulation of DNA damage and chromosomal instability. RECQ1 binds and unwinds DNA structures that represent intermediates of DNA recombination repair, and interacts physically and functionally with proteins involved in regulating genetic recombination. Moreover, RECQ1-deficient cells are more sensitive to DNA damage and display spontaneously elevated sister chromatid exchanges reminiscent of aberrant repair of stalled replication forks. We hypothesize that RECQ1 plays critical roles in ensuring genome stability by virtue of its catalytic actions and specific interactions with cellular protein partners. To test this hypothesis, we are proposing systematic analyses of the biochemical and cellular characteristics of RECQ1. We will elucidate how biochemical activities of RECQ1 allow it to achieve its putative functions in genome stability maintenance by: 1) elucidating role(s) of RECQ1 in DNA repair pathways of genome stability maintenance; 2) determining critical amino acid residues of RECQ1 essential for specific catalytic and cellular functions; and 3) identifying novel protein interactions of RECQ1 using unbiased biochemical approaches and investing their functional significance. Results from these studies will be important to establish biological roles of RECQ1. This should facilitate dissecting the molecular details that explain similarities and differences in the biological functions of human RecQ helicases in pathways of genome stability maintenance to prevent cancer and premature aging.

Public health relevance
PUBLIC HEALTH RELEVANCE: RECQ1 belongs to the RecQ family of DNA helicases members of which are associated with rare diseases of premature aging and cancer predisposition in humans. Thus, the functions of RecQ helicases have a direct impact on human health. The presence of multiple RecQ homologs in humans indicates functional specialization; elucidating the molecular function(s) of RECQ1 helicase should, therefore, provide important insights to the mechanisms of genome stability maintenance that prevent development of cancer and early onset of aging. Project Relevance RECQ1 belongs to the RecQ family of DNA helicases members of which are associated with rare diseases of premature aging and cancer predisposition in humans. Thus, the functions of RecQ helicases have a direct impact on human health. The presence of multiple RecQ homologs in humans indicates functional specialization; elucidating the molecular function(s) of RECQ1 helicase should, therefore, provide important insights to the mechanisms of genome stability maintenance that prevent development of cancer and early onset of aging. __SpecificAimsTextDelimiter__ A. Specific Aims Genomic instability is a known precursor to cancer and aging. We have recently discovered that RECQ1 is critical for maintaining genomic stability. RECQ1 is a member of the highly conserved RecQ family of DNA helicases that play key roles in genome maintenance in all living organisms. Human RecQ homologs include RECQ1, BLM, WRN, RECQL4, and RECQ5, three of which have been individually linked to specific diseases. RecQ-related diseases are characterized by a variety of clinical features ranging from growth defects (Bloom Syndrome and Rothmund-Thomson Syndrome) to premature aging (Werner Syndrome), but all these patients have a high risk of developing cancers. Thus, a defect in one RecQ protein is sufficient to cause cellular transformation and tumorigenesis that cannot be compensated by other RecQ proteins. This suggests functional specialization of multiple human RecQ homologs; however, what makes the human RecQ proteins different from each other to cause distinct clinical phenotypes is only poorly understood. My long-term objective is to characterize the functions of individual RecQ proteins, and compare the similarities and differences among the RecQ homologs. This should reveal which aspects of RecQ functions in genome maintenance are essential for normal development and cancer prevention. The goal of this proposal is to establish functions of RECQ1 helicase, the most abundant but least characterized human RecQ homolog. Knockout of the RECQ1 in mice or knockdown of its expression in HeLa cells results in chromosomal instability, elevated frequency of spontaneous sister chromatid exchanges and heightened sensitivity to ionizing radiation. RECQ1-deficient cells display increased DNA double strand breaks and accumulation of potentially unresolved recombination events. In human cells, RECQ1 interacts physically and functionally with mismatch repair proteins that are involved in the regulation of genetic recombination. The recombinant human RECQ1 preferentially binds and unwinds substrates that model DNA recombination repair intermediates in vitro. Moreover, RECQ1 is a predominant Holliday junction branch migration activity in human cell extracts and possesses branch fork migration activity in vitro. Thus, we hypothesize that RECQ1 plays critical roles in ensuring genome stability by virtue of its catalytic actions and specific interactions with cellular protein partners. We will test this hypothesis through the following Specific Aims: Specific Aim 1. Elucidate role(s) of RECQ1 in genome stability maintenance. We will use RECQ1-deficient (knockout mouse and siRNA-transfected human cells) and proficient cells to (a) determine the role(s) of RECQ1 in response to DNA damage; (b) determine whether RECQ1 is involved in the homologous recombination repair of a DNA double strand break; and (c) further investigate the nature of genomic instability in RECQ-1 deficient cells under normal and genotoxic stress conditions. Specific Aim 2. Determine critical amino acid residues of RECQ1 essential for specific catalytic and cellular functions. We will perform site-directed mutagenesis of the conserved helicase and RQC domain of RECQ1 to (a) determine amino acid residues in RECQ1 critical for its catalytic functions in vitro; and (b) achieve functional complementation of cellular RECQ1-deficiency for correction of elevated spontaneous sister chromatid exchanges. Specific Aim 3. Identify novel protein interactions of RECQ1. To discern molecular functions of RECQ1 in genome maintenance, we will perform (a) isolation of endogenous RECQ1 complex(s) by immunoprecipitation, (b) affinity purification of the tagged RECQ1 protein from human cells, and identify RECQ1-interacting proteins by mass spectrometry; and (c) investigate functional significance of RECQ1 protein interactions in DNA repair. PI's Developmental Objectives: The proposed research will elucidate how biochemical activities of RECQ1 enable it to achieve its functions in genome maintenance, both independently as well as in cooperation with other cellular proteins. In addition to establishing roles of RECQ1, these results will contribute to my overall objective of delineating redundant and specialized functions of human RecQ homologs. To affirm myself as an independent investigator, my immediate objectives include: 1) increasing research productivity to make significant contributions and attain a greater recognition in the field; and 2) establishing a more extensive research network. To achieve my research and developmental goals, I am collaborating with experts in the field of DNA helicases and DNA repair (see letters of support); their expertise and advice will certainly strengthen the current project and will likely serve as a great resource for future projects as well. In conclusion, receiving a SCORE grant will serve as an important foundation for me to advance my research elucidating molecular mechanisms of RecQ helicase functions, and to complete and publish the work proposed in this application in order to establish myself as an independent investigator. I am confident that within 3 years or less, my curriculum will be sufficiently strong to submit my future work to NIH as an RO1 application.